ELECTRON CRYSTALLOGRAPHY OF 50 S RIBOSOMAL SUBUNITS

We have tried different lipids and protein concentration to get better crystals of 50S ribosome subunits. So far, we have not seen any significant improvement in the crystal quality.